Integrated Platform for Discovery and Validation of Probes that Restore Protein Expression in Single-Gene Causes of Autism and Related Disorders

PROJECT SUMMARY

Drug discovery pipelines for neuropsychiatric disorders are dry. One approach to rejuvenating these
pipelines would be to create assays based on relevant disease phenotypes in primary neurons, something that
is currently lacking. However, a scalable assay development platform that is based on bona fide neurons,
remains cost effective, and that can support industrial level high-­throughput screening (HTS) does not currently
exist. Over the past eight years (spread across different NIH-­sponsored grants), our collaborative group has
created a flexible and scalable primary neuron-­based assay development system that is compatible with
industrial-­level HTS. Our long-­standing goal for this project has been to optimize these procedures and
workflows to support neuron-­based HTS phenotypic assays so that they can support very large
screening campaigns of up to 200K compounds.
We are happy to report that progress over the last budget period has pushed us closer toward this
stated goal. We have invented a state-­of-­the-­art, disease-­modeling assay created in primary neurons that is
designed to discover compounds that reverse the cellular consequences of genetic haploinsufficiency. Indeed,
a substantial proportion of childhood brain disorders are caused by single autosomal dominant variants
resulting in genetic haploinsufficiency. The rare genetic brain disorders that arise from these variants offer
great potential for translation because the disease mechanism is well-­understood (i.e. low protein expression).
Therefore, a rationale precision therapy for treating genetic haploinsufficiency disorders would be to discover
“magic bullet” compounds that raise expression of functional proteins from the remaining undamaged allele
(e.g. “boosting compounds”). In this renewal project, we will employ technical innovations that have unlocked
the scalability of primary neurons for phenotypic HTS. As a proof-­of-­principle, we will scale-­up and
implement an assay that reports reversal of low SynGAP expression in neurons caused by genetic
haploinsufficiency of the SYNGAP1/Syngap1 gene. We will miniaturize an HTS-­compatible and disease-­
modeling steady-­state endogenous SynGAP expression assay so that it is compatible with industrial scale HTS
automation. Once implemented, we will then screen up to 200,000 unique substances using a completely
automated version of the neuron-­based SynGAP expression assay. Finally, using a comprehensive multi-­stage
biological validation funnel, we will identify and prioritize the most translatable chemical probes that raise
SynGAP protein expression. The overall impact of this project is that discovery of multiple, validated SynGAP
boosting compounds would provide proof-­of-­principle that our flexible platform is an effective tool for
phenotypic drug discovery for nervous system disorders.

Public health relevance
NARRATIVE One approach to rejuvenating drug pipelines for neuropsychiatric disorders is to create HTS scalable assays based on relevant disease phenotypes in primary neurons, though a cost effective platform for true HTS- compatible neuron- based phenotypic assays does not currently exist in academia. As a means to refine our novel neuron- based HTS system, and to advance treatment for ASD- related disorders, we are seeking to scale- up and implement a primary neuron- based phenotypic assay that can reveal chemical probes capable of reversing the root cause of a rare genetic brain disorder.